Function of Engrailed-1 in eccrine gland development

DESCRIPTION (provided by applicant): The goal of this research is to identify the mechanisms by which eccrine glands are formed with the ultimate aim of regenerating eccrine glands in damaged human skin or in vitro generated skin grafts. Although the expression of En-1 in the ectoderm has been implicated in eccrine gland development in the mouse, the overlapping requirement of engrailed-1 activity for the normal development of the ventral limb in which sweat glands are found has precluded separation of a direct role for En-1 in eccrine gland development from an indirect role in specifying ventral identity. Recently we have generated additional evidence that En-1 plays a direct role in eccrine development. We will dissect that function using an inducible transgenic model and a novel in vitro eccrine gland development assay to test the function of En-1 expression in regulating eccrine gland development. The mechanisms of this effect will be dissected by separating direct effects in the epidermis from indirect effects on the inductive properties of the underlying dermis. Successful completion of these aims will identify the function of En-1 and develop a platform for efficient in vitro analysi of eccrine gland development. The endpoint assay in this work is the in vitro development of eccrine glands, and as such provides direct insight to regeneration of eccrine glands in skin equivalents.

Public health relevance
PUBLIC HEALTH RELEVANCE: Progress towards the ability to regenerate sweat glands in damaged human skin is impeded by ignorance of the basic mechanisms that distinguish eccrine sweat gland development from that of other cutaneous appendages like hair follicles and sebaceous glands. The proposed work tests the idea that expression of the En-1 gene in otherwise competent epidermis drives eccrine gland development in response to dermal signals. If this hypothesis is proven correct, it not only provides insight into En-1 function, but creates the conditions that will allow rapid identification of other signals required for eccrine gland development.